Biomimetic Apoptotic Particles for Macrophage-driven Oral Bone Regeneration

ABSTRACT
Adequate bone quality, quantity, and wound repair in the oral cavity are crucial for treatment eligibility, as well
as short and long-term success of dental implants. Successful restoration of a functional dentition requires an
understanding of the endogenous bone repair process. Often overlooked, one of the first steps in osseous wound
repair after trauma, such as in a dental extraction, is cell death and subsequent apoptotic cell (AC) clearance
(efferocytosis) by macrophages. As a result of efferocytosis, macrophages secrete a variety of factors that
facilitate regeneration, and swiftly alter their behavior in response to a multitude of physical and biological
microenvironmental cues. CC-motif chemokine ligand 2 (CCL2), which is secreted by macrophages, mediates
mesenchymal stem/progenitor cell (MSPC) recruitment to the wound site. Although previous work has largely
focused on biochemical signals that drive CCL2 production, preliminary data in the current proposal suggests
that the physical nature of AC engulfment drives cytoskeletal events and subsequent mechanotransductive
signaling. Engulfment of apoptotic cells induces changes in macrophage shape, actin organization, and nuclear
architecture that likely initiates CCL2 production. Understanding efferocytosis-induced intracellular forces and
resulting signaling will inform the design of apoptotic cell mimics (ACM) as a regenerative therapy for patients
whose age or co-morbidities impair wound healing capacity. The goals of this project are to determine the role
of efferocytosis-induced macrophage mechanotransduction in bone repair and to promote reparative
macrophage behavior using ACM, hence catalyzing the endogenous osseous wound healing response. The
overall hypothesis is that macrophages promote osteogenic repair through efferocytosis-driven
biophysical signaling, which can be recapitulated using apoptotic cell mimicry for a regenerative
advantage. The two aims proposed are: 1) to connect CCL2 expression and macrophage phenotype with AC
and ACM engulfment-induced changes to the cyto- and nucleoskeleton, and 2) to optimize and deliver ACM to
promote macrophage-driven osteogenesis and improve bone repair in a clinically relevant oral osseous wound
healing model. To accomplish these aims, first an in vitro co-culture system that allows for macrophage
engulfment of AC and ACM will be used. This will be a valuable tool to identify and validate genes and proteins
associated with mechanotransduction and osteogenic-repair that are similarly altered in both experimental
groups. ACM with tunable size, stiffness, and degradability will be optimized to maximize CCL2 secretion given
its role in MSPC recruitment. Next, we will use CCL/R2 genetic knockout mouse models to confirm the role of
CCL2 in bone regeneration. We anticipate ACM treatment will induce cytoskeletal changes that result in CCL2
production and promote bone repair. The outcomes of this project will identify underexplored effects of post-
efferocytosis macrophage mechanotransduction and reparative activity, providing mechanistic insights into bone
regeneration, which can be used to establish new bone regeneration therapies for patients.

Public health relevance
PROJECT NARRATIVE In the U.S., more than half of adults are missing at least one permanent tooth and more than 5 million dental implants are placed annually, with numbers expected to increase due to a growing and aging population. Since inadequate bone quality, quantity, and wound repair in the oral cavity can compromise short and long-term success of dental implants, developing new strategies to enhance bone regeneration is necessary to enable and support dental implant use in more patients. In this project, a biomaterial-based imitation of the natural process of clearing dead and dying cells by macrophages (key immune system cells) will be investigated as a promising strategy to enhance oral wound healing and bone regeneration.